Promoting Health, Safety, and Recovery Training following Declared Disasters in 2022

Project Summary/Abstract
The overall goal of this WRUC administrative supplement is to increase the knowledge and skills of
tribal emergency responders, day laborers, and migrant workers engaged in response and recovery
efforts related to recent major environmental disasters in the Western Region. Our approach
leverages existing relationships and infrastructure under our HDPT grant to quickly roll out training
resources, both in response to recent severe storms and floods and in preparation for future
disaster events.
Under this initiative, WRUC will partner with the Northwest Tribal Emergency Management Council
(NWTEMC), the National Day Laborer Organizing Network (NDLON), and several California-based
organizations to extend needed training resources to these impacted communities and worker
populations. Proposed activities include a) training for tribal emergency responders provided as
part of NWTEMC’s annual conference and in support of a planned 2024 multistate tribal-led
NWTEMC simulation exercise; b) Training-of-Trainers for staff and worker-leaders from NDLON and
other trusted worker and community organizations with access to day laborers and migrant disaster
workers in Washington State and California; and c) a regional partner workshop on Disaster
Resilience for Climate-Vulnerable Populations to share lessons learned and to identify future
climate disaster response and resiliency needs. These activities expand on the core objective of our
parent grant to expand disaster preparedness and emergency response capacity in our region.
Total projected training over the two-year funding period: 71 courses, 1,283 trainees, 4,810
contact hours

Public health relevance
Project Narrative The overall goal of this WRUC administrative supplement is to increase the knowledge and skills of tribal emergency responders, day laborers, and migrant workers engaged in response and recovery efforts related to recent major environmental disasters in the Western Region. In addition, we will build the capacity of trusted worker and community organizations to provide information and support to these populations during current and future disasters. The proposed work builds on existing WRUC partnerships and initiatives to meet time-sensitive needs of workers on the frontlines of disaster response and recovery work.